Emory Integrated Genomics Core

EMORY INTEGRATED GENOMICS SHARED RESOURCE
PROJECT SUMMARY/ ABSTRACT
The Emory Integrated Genomics Core Shared Resource (Genomics SR; Categories 1.16, 1.21, and 1.35)
provides services allowing scientists to conduct deep genomic sequencing, probe gene expression and
methylation patterns in a tissue sample, or search for mutations in an individual's DNA or in a tumor. The central
mission of this facility as a Winship shared resource is to support the research efforts of Winship members by
providing exceptional cancer genomics services Genomics SR provides services in research and CLIA settings
which include nucleic acid extraction, Illumina sequencing, high-density microarray services on both the
Affymetrix and Illumina platforms, targeted enrichment, and single nucleotide polymorphism (SNP) genotyping.
Significant improvements in shared resource organization and efficiency have increased capacity, lowered costs,
and increased service offerings. Service offerings for Illumina next generation sequencing (NGS) have
dramatically increased after the adoption of a broker model in which all large-scale service requests are
competitively outsourced to one of several academic or commercial vendors. New services, including
microbiome and single cell services, have been launched for Winship members. Genomics SR has maintained
its CLIA license (CLIA: 11D1086150) and developed closer ties with the Emory Genetics Laboratory, which is
now offering clinical cancer diagnostic testing. Improved access to computational resources through the Emory
Integrated Computational Core (EICC) and increased collaboration with Winship’s Biostatistics and
Bioinformatics Shared Resource (BBISR) have significantly enhanced the analysis of large-scale genomics data
sets by Winship members. As a consequence of these changes, usage by Winship members have significantly
increased during the current funding period. Genomics SR currently provides valuable services in support of
Winship discovery and is well positioned to adopt novel genomic services which will advance Winship research.